Rush Alzheimer's Disease Research Center

ABSTRACT – OVERALL
The overall goal of the proposed Rush ADRC is to create an inter-disciplinary environment that supports
innovative research on the causes, treatments, and prevention of AD/ADRD. While the proposed Rush ADRC
is for a new grant, it builds on three decades of work by the current Rush ADCC. The Rush ADRC has eight
cores and one component, which align with the recommendations of the 2017 NIA strategic plan, including
studies that: 1) recognize the heterogeneity and multifactorial nature of dementias; 2) support extensive
molecular profiling to fill the gaps in large-scale human data needed to build predictive models of disease and
wellness; 3) employ new research paradigms, e.g., systems biology, human cell modeling; 4) enable rapid and
extensive sharing of data, disease models, specimens, and support open and team science; 5) develop
computational tools and infrastructure for storage, integration, and analysis of large-scale biological and
patient-relevant data; 6) build multidisciplinary translational teams in virtual and real spaces; 7) develop new
pre-competitive public-private partnerships; 8) change academic, publishing, and funding incentives to promote
collaborative, transparent, and reproducible research; and 9) engage patients, caregivers, and citizens as
direct partners in research.
The Administrative Core will provide scientific leadership to the Rush ADRC as a whole. The Religious Orders
Study (ROS) Core will recruit and conduct annual evaluations of Catholic clergy without dementia who agree to
organ donation. The Clinical and Latino Cores will collect data harmonized with on Blacks and Latinos without
dementia and work to obtain brain autopsy. The Neuropathology Core will process, store, evaluate and
distribute biospecimens obtained by the Clinical, ROS, and Latino Cores. The Outreach, Recruitment, and
Engagement Core will provide a wide range of educational programs to support outreach and recruitment of
racial and ethnic minorities into the Clinical, ROS and Latino Cores, and other NIA funded initiatives. The
Biomarker/Neuroimaging Core will process neuroimaging generated with other funds from all three Cores and
affiliated studies, and document neuroimaging and biofluid biomarker data. The new Research and Education
Component will provide structured mentoring of students and faculty at all levels. The Data Management and
Statistical Core will provide the infrastructure that allows all other Cores and the REC to be maximally
successful and impactful and will provide statistical support to users of ADRC resources especially junior
investigators and trainees.

Public health relevance
PROJECT NARRATIVE – OVERALL The prevention of cognitive decline, MCI and dementia is a major public health priority. The proposed Rush ADRC will build on three decades of a successful ADCC and generate resources to support a deeper understanding of the pathogenesis of MCI and dementia, and to identify novel therapeutic targets for its treatment and prevention.